A theoretical framework and mixed-methods investigation of documentation status as a social determinant of emergency care utilization in adult safety-net patients

PROJECT SUMMARY/ABSTRACT
BACKGROUND: As a historically minoritized and marginalized population, undocumented immigrants
residing in the US face unique and intersecting social and structural inequities in health care access and
outcomes. Undocumented immigrants are significantly more likely to report limited access to health
insurance coverage, less use of preventive health services, and worse health outcomes as compared to
their documented counterparts. Due in-part to exclusionary policies limiting access to comprehensive health
insurance coverage, many undocumented immigrants are left with little to no choice but to search for
alternative care seeking strategies, including use of safety net emergency departments (EDs) for potentially
preventable conditions when experiencing health needs. However, undocumented immigrants remain largely
underrepresented in the emergency care utilization literature. ED utilization for ambulatory sensitive care
conditions (ACSCs) - conditions for which good outpatient care and early intervention can prevent
complications, hospitalization, or more severe disease – are a costly form of health care that have been
associated with various social determinants of health, including lack of insurance, however, documentation
status as a social determinant of ED utilization for ACSCs is notably missing in the health utilization
literature. METHODS: I propose an in-depth investigation of documentation status as a social determinant of
ED utilization for ACSCs and non-ACSC in the safety-net setting. In addition to studying the ED care seeking
behaviors of adult safety-net patients by various demographic and clinical factors, I will also use project
results to propose policy and program solutions for reducing inequities in care and access in the safety-net
setting. To accomplish these objectives, I will pursue the following specific aims: 1) Use a traditional
grounded theory approach to conduct n=25-30 qualitative interviews on various interpersonal, sociocultural,
and structural influences of emergency care seeking behaviors in documented and undocumented adult
patients; 2) Use a concatenated, county-wide administrative, billings, and claims dataset to identify
demographic and clinical characteristics of potentially preventable vs. non-preventable emergency
department utilization among documented and undocumented adult patients at an urban safety-net ED; and
3) Merge datasets from Specific Aims 1-2 and conduct a comprehensive mixed-methods analysis of how
various clinical, interpersonal, sociocultural, and structural influences of emergency care seeking intersect,
diverge, and converge among and within distinct case-comparison groups – including reason for admission
and disposition, country of birth and primary language, and insurance type and housing status - in
documented and undocumented adult patients at an urban, safety-net ED. RESULTS: By providing a
comprehensive understanding of documentation status as a social determinant of ED utilization in the safety-
net setting, this project will help identify the best immediate and long-term policy and program solutions for
improving access to equitable, quality healthcare for documented and undocumented safety-net ED patients.

Public health relevance
PROJECT NARRATIVE As a historically minoritized and marginalized population, undocumented immigrants residing in the US face unique and intersecting social and structural inequities in health care access and outcomes, however, they remain vastly underrepresented in existing health services utilization literature, particularly in the safety-net setting. I propose an in-depth mixed-methods investigation of documentation status as a social determinant of emergency department (ED) utilization for ambulatory care sensitive conditions (ACSCs) and non-ACSCs in the safety-net setting. By providing a comprehensive understanding of documentation status as a social determinant of ED utilization in the safety-net setting, this project will help identify the best immediate and long-term policy and program solutions for improving access to equitable, quality healthcare for documented and undocumented safety-net ED patients.